International Workshop on Advances in Electrocorticography

Project Summary/Abstract The objective of this workshop is to bring together engineers, scientists and clinicians involved in ECoG/SEEG research; to educate them about ECoG/SEEG physiology; to help them formulate important scientiﬁc and clinical questions for ECoG/SEEG research; to facilitate interactions and collaborations among them; and to summarize advances in ECoG/SEEG research in an annual proceedings article. The program has been designed to engage scientists, engineers, and clinicians who wish to use ECoG/SEEG recording and stimulation techniques to study the neural mechanisms underlying uniquely human mental abilities for which adequate animal models do not exist. This format follows our extremely successful series of 14 workshops held since 2008. These workshops have each been able to accommodate up to 120 participants. To date, the results of these workshops have been reported in seven highly visible proceedings articles that were published by Epilepsy and Behavior.

Public health relevance
Project Narrative This workshop aims to provide training in the theory and practice of ECoG/SEEG to scientists, engineers, and clinicians who wish to apply them to important scientiﬁc and clinical problems. This will advance the access of scientists, engineers and clinicians to ECoG/SEEG recording and stimulation expertise. This grant will expand the outreach of this workshop by promoting attendance of medical residents, postdoctoral researchers, and graduate students.